Prevention of HIV Infection in High-Risk Social Networks of African American MSM

DESCRIPTION (provided by applicant): Risk for HIV infection in the United States falls along sharp lines of disparity related to sexual orientation and race/ethnicity. HIV infection has always taken a heavy toll on men who have sex with men (MSM) and also on African Americans. However, HIV incidence disparity is most striking of all for MSM who are also African American, a segment that probably accounts for less than one percent of the American population but fully 25% of all new HIV infections in the United States. Surprisingly, very few HIV prevention interventions designed for African American MSM have been undertaken, and most existing approaches have relied on individual or small-group risk reduction counseling. These existing models have limited cultural and practical suitability for reaching high-risk African American MSM who are hidden in the community and unlikely to seek out sexual risk reduction counseling. Interventions directed to individuals alone also do not attend sufficiently to the important influence played by social norms and social network factors on risk behavior. In contrast to individual counseling models, HIV prevention interventions that are directed to social networks of Black MSM in the community and that work through natural influence channels within these networks hold the potential for reaching deeply into hidden and vulnerable populations of African American MSM. Network-level HIV prevention interventions rely on oral communication traditions and cultural models appropriate in minority communities, and can strengthen social network normative support for risk reduction. Following a 1-year formative research phase that will provide data needed to contextualize the study's recruitment, assessment, and intervention content and delivery methods, we will undertake a social network-level intervention outcome trial in 3 cities: Milwaukee, Cleveland, and Miami. Project-wide, 24 sociocentric networks of African American MSM-each expected to be composed of approximately 40 people (total n=960 participants)-will be recruited. 12 of the networks (n=480 participants) will be randomized to a comparison condition and receive HIV/STD testing, treatment, and individual counseling. The other 12 networks (n=480) will receive the same counseling and testing and also a social network intervention that identifies, trains, and engages empirically-identified influence leaders of each network to deliver ongoing, theory-based, and culturally tailored HIV prevention advice, recommendations, and support to other network members. The study will determine the comparative effectiveness of the social network intervention to the counseling, testing, and treatment comparison condition on measures of sexual risk, substance use associated with sexual risk behavior, and STD/HIV incidence assessed with laboratory measures at 6- and 18-month followup points. The study aim is to develop and determine the efficacy of an intervention modality capable of reaching and preventing HIV among high-risk African American MSM in the community.

Public health relevance
PUBLIC HEALTH RELEVANCE: 56,000 Americans continue to contract HIV each year, and African American MSM account for a far disproportionate number of incident infections. Public health efforts to reduce HIV incidence in the United States require the development of new prevention approaches delivered using modalities that can target and reach those population segments at greatest vulnerability. If successful, this research will identify an HIV prevention intervention approach, practical for public health service providers, that lends itself well to rapid uptake and use by CBOs, health departments, and minority organizations concerned about AIDS. PREVENTION OF HIV INFECTION IN HIGH-RISK SOCIAL NETWORKS OF AFRICAN AMERICAN MSM Project Narrative 56,000 Americans continue to contract HIV each year, and African American MSM account for a far disproportionate number of incident infections. Public health efforts to reduce HIV incidence in the United States require the development of new prevention approaches delivered using modalities that can target and reach those population segments at greatest vulnerability. If successful, this research will identify an HIV prevention intervention approach, practical for public health service providers, that lends itself well to rapid uptake and use by CBOs, health departments, and minority organizations concerned about AIDS. __SpecificAimsTextDelimiter__ SPECIFIC AIMS 56,000 Americans contract HIV infection each year, nearly 40% greater than the 40,000 new cases per year that had long been estimated (Hall et al., 2008). Throughout its nearly 30-year history, HIV/AIDS has most harshly affected men who have sex with men (MSM), who accounted for over half of new HIV infections diagnosed in the United States in 2007 (CDC, 2009). Also constant throughout its entire history, HIV/AIDS has taken a very heavy toll on communities of color, especially Black communities. African Americans constitute approximately 12% of the American population, but account for 47% of its HIV/AIDS cases (CDC, 2008[6]). Although the disease has placed disproportionate burden separately on MSM and on African Americans, the most shocking health disparity impacts persons who are both MSM and also African American. Black MSM probably constitute less than one percent of the total American population (Binson, Michaels, Stall et al., 1995; Laumann et al., 1994). However, African American MSM constituted fully 25% of all new HIV infections in the United States in 2007, a 25-fold level of over-representation (CDC, 2009). The most typical profile for a new HIV infection in much of the country is an African American gay or bisexual man in his 20s. Given this enormous disparity, one would expect to find a great deal of public health research attention directed to HIV prevention interventions for African American MSM. Sadly, this is not the case. Few published reports have described outcomes of well-controlled HIV prevention intervention trials specifically tailored for African American MSM, and none have employed disease reduction endpoints. While several randomized trials of behavioral interventions for MSM have included a small percentage of minority men, the intervention models employed in these trials have generally relied on individual or small-group counseling. African American MSM often do not self-identify as gay, often perceive strong homophobic stigma, and often are not openly "out" concerning their same-sex behavior. Consequently, individual or group counseling models that require persons to publicly present themselves to seek risk behavior change assistance are unlikely to reach more than a tiny proportion of at-risk minority men. A more promising approach for reaching African American MSM in the community-and reaching even hidden men in a manner congruent with their culture and lifestyle-is with an intervention directed to permeate natural social networks of minority MSM. For 6 years, our research team carried out trials of HIV prevention interventions aimed at decreasing sexual risk behavior within hidden, stigmatized, ethnic minority, and hard-to-reach community populations in Eastern Europe. This work, unique to the field, has shown that it is possible to locate and recruit high-risk and interconnected social network members in the community, to employ social structure analyses to identify influence leaders within these networks, and to engage network leaders to advocate for risk reduction behavior change among other members of the same network (Amirkhanian, Kelly, & McAuliffe, 2005). Our international work established that this intervention model can reduce the prevalence and frequency of high-risk sexual behavior practices and can decrease STD incidence of network members (Amirkhanian, Kelly et al., 2005; Kelly, Amirkhanian et al., 2006). Intervening to promote and diffuse behavior change within high-risk social networks also represents a promising and culturally congruent strategy for reaching African American MSM. A pilot test of the social network intervention with Black MSM, completed in preparation for this resubmission, also yielded very promising outcomes and high levels of community acceptance of the model. This proposed study will test the impact of a social network-level HIV prevention intervention for African American MSM. The trial's primary outcomes are reductions in high-risk sexual behaviors, substance use, and HIV/STD incidence. The study will be undertaken in collaboration with community partner agencies in three city sites: Cleveland, Milwaukee, and Miami. Specific aims of the study are: 1. During a 1-year formative research phase, each site will undertake formative studies to locate, understand, and characterize high-risk social networks of African American MSM in its community; gain African American MSM community participation, involvement, and input into the research; and undertake interviews with key informants and community members to gain information needed to refine and pilot test study recruitment procedures, measures, and intervention content; 2. During a 4-year main outcome trial phase, each site will enroll 8 separate sociocentric ("bounded") social networks composed predominantly of Black MSM. Each sociocentric network will consist of the ring of friends surrounding an initial high-risk index as well as all friends surrounding persons in this second ring and then friends surrounding a successive third snowball ring of enrollees. Each 3-ring sociocentric network is expected to consist of approximately 40 unique members (studywide n=24 networks, each with 40 members=960 individual participants). 3. All study participants will be individually assessed at baseline to measure sexual practices, substance use, and other risk characteristics over the past 3 months; asked to provide biological specimens to be tested for HIV, STDs and drug use; and individually counseled in HIV/STD risk reduction. STDs will be treated and those with HIV will be referred for treatment. Social networks will then be randomized to intervention or comparison arms such that 12 sociocentric networks (480 participants) are assigned to each study arm. Participants in comparison condition networks will receive the STD/HIV testing, treatment, and counseling that takes place in the baseline assessment visit. Participants in intervention condition networks will also receive the social network intervention being tested in this trial; 4. Social structural analyses will identify the individuals in intervention condition networks with the greatest number of reciprocal interconnections and the most favorable sociometric standing with others in the network. These individuals-expected to constitute approximately 20% of the sociocentric network and designated as its network leaders-will be recruited to attend a 9-session program that provides training and guidance in how to deliver ongoing, theoretically-based, and culturally tailored risk reduction advice and counseling to other members within the same network. Topics, content, language, and contextual factors addressed in network leader training sessions-and in the advice leaders give to others-will be tailored to the cultural themes that emerged in the first year formative studies and will be imbedded into the core components of the intervention; 5. Six and 18 months following the intervention, all participants in both conditions' networks will be reassessed on risk behavior and STD/HIV and drug use laboratory measures as well as measures of intervention exposure, with positive STD and HIV cases respectively treated or referred to care at each assessment point. Outcome analyses will test whether there is greater reduction in high-risk sexual practices, substance use associated with risky sex, and HIV/STD incidence within social networks in the intervention condition arm. The primary trial endpoints are reductions in prevalence and frequency of unprotected anal intercourse with nonexclusive partners, increased condom use, and lower incidence on a composite biological measure of new disease during the followup period. Economic analyses will use prospective cost data to ascertain the cost-effectiveness of the network intervention. Finally, the data will provide rich opportunities for secondary analyses to explore relationships between social network characteristics, sexual networks, sexual risk behavior, substance use, and HIV/STD incidence in a large sample of African American MSM. If successful, this research will identify a prevention model urgently needed by public health providers to confront an HIV epidemic that takes its greatest toll on African American MSM. The intervention approach is novel in the United States but is based on a strong social network research foundation, our earlier use of this model in international settings, and promising results in our pilot study with Black MSM. If found effective in the proposed trial, this intervention model will be well-suited for rapid dissemination and uptake by service providers, agencies and community-based organizations.